Engineered microglia for the treatment of Adult-onset Leukoencephalopathy with Axonal Spheroids and Pigmented Glia (ALSP)

Adult-onset leukoencephalopathy with axonal spheroids and pigmented glia (ALSP) is a neurodegenerative
disease that is caused by a mutation in the colony stimulating factor-1 receptor gene, leading to microglia
dysfunction and loss, cognitive and behavioral decline, and impaired motor activity. ALSP is a rare disease with
accumulating evidence that it is underdiagnosed, owing to its similarities to other neurodegenerative disease.
The standard of care for ALSP is limited to supportive care; it is 100% fatal and there are no effective treatments.
The NovoGlia technology platform uniquely uses induced human pluripotent stem cells to produce human
microglial cells, called iMGL. The transplantation of wild-type iMGL into a mouse brain results in robust
engraftment of iMGL that acquires transcriptional and functional profiles mirroring those of endogenous human
microglia. Transplanted iMGL can both prevent and reduce ALSP-related pathologies in a mouse model of the
disease. To build on these proof-of-concept studies, the proposed work is focused on validating an ex vivo gene
correction strategy and ensuring the safety, therapeutic efficacy, and delivery of an autologous cell replacement
therapy. The project encompasses validating a gene corrected protocol, demonstrating the safety and tolerability
of the iMGL product, and completing the development of a custom-designed cannula device suitable for
intraparenchymal cell delivery to the CNS. These efforts aim to provide the necessary preclinical data to support
an Investigational New Drug (IND) application, with the potential to significantly improve treatment for ALSP and
extend patient survival.

Public health relevance
The objective of this work is to advance a novel microglia cell replacement therapy for diseases with microglia deficiency. This strategy has the potential to be developed into new therapies to treat patients with microgliopathies, for which there is no cure.